ADMINISTRATIVE SUPPLEMENT - TargetAD: A systems multi-omics approach to drug repositioning in Alzheimer's disease

Project Summary
Late-onset Alzheimer's Disease (AD) is a slowly progressing, untreatable neurodegenerative disorder that
affects a substantial fraction of the aging population today. Hundreds of clinical trials and massive investments
into drug development efforts have so far not resulted in a single disease-modifying therapy that showed a
significant beneficial effect on the disease. Drug repositioning, the application of approved drugs in a novel
disease context, has gained increasing attention as a promising alternative to identify treatment options for AD.
For successful pharmaceutical intervention in AD, a drug or drug combination needs to target the complex
molecular changes observed in AD in a specific manner. To identify drugs exerting these desired effects a
detailed understanding of the molecular networks across regulatory layers that underly the biological system is
required. However, these networks are not readily available and are scattered across hundreds of studies and
complex databases. To address this challenge, we propose TargetAD, a network-based framework that builds
this molecular network from genetic associations, co-expression/correlation networks, metabolic pathways, gene
regulation data, protein-protein interactions, and tissue-specific gene and protein expression data augmented
with AD multi-omics associations, as well as drug-drug target data and molecular drug signatures. We will
achieve this by leveraging the power of large-scale, multi-omics association results generated within NIH's large
“Accelerating Medicines Partnership - Alzheimer's Disease” initiative and other large-scale population-based
studies. The collective evidence will be stored in a publicly accessible graph database, which we then use for
the identification of candidate drugs or drug combinations (“candidates”).
Through the development of a novel network-based machine-learning method, we will rank candidates in the
database by their probability to affect AD networks in a beneficial way. High-ranking candidates will be subjected
to a comprehensive prioritization pipeline. To this end, we will retrospectively investigate whether longitudinal
AD-related biomarker profiles of individuals who took a repositioning candidate show evidence for healthier aging
in large studies of AD. These analyses will be complemented by examining whether the post-mortem
neuropathological burden supports a beneficial effect of the candidate. To increase power and coverage of
candidates, we will further analyze electronic health records from the UK Biobank for additional evidence. The
three most promising candidates will be selected in discussion with a panel of experts. These will be evaluated
by preclinical validation studies in animal models of AD.
In summary, the unique combination of multidisciplinary expertise, access to high-profile datasets and advanced
computational integration pipelines will allow us to identify molecular pathways disturbed in AD that are
targetable by drug repositioning candidates, which thus are prime candidates for testing in clinical trials.

Public health relevance
Project Narrative Drug repositioning - the application of approved drugs in a novel disease context - has gained increasing attention as a way to identify alternative treatment strategies for Alzheimer's Disease (AD). We here propose a novel machine-learning approach to identify drug repositioning candidates in a network-based framework by combining multi-omics associations from large studies of AD with molecular pathway information, extensive drug- drug target data, as well as molecular drug effect data. In silico repositioning candidates will be further prioritized through retrospective analyses in studies of AD and large-scale mining of electronic health records, and the resulting top three candidates will be experimentally validated in mouse models of AD.